Transitional MARC-U-STAR-UPRM toward a Diversity Enhancement restructuring

Project Abstract The MARC U-STAR Program, now in its 30th year at the University of Puerto Rico-Mayaguez Campus, is designed to provide honors students with meaningful research related experiences, and a special science curriculum, coupled to scientific service learning and professional development activities that will propel their competitiveness in pursuing doctoral programs in biomedical sciences. Twenty two honors students from the biology, industrial microbiology, chemistry, industrial biotechnology, and chemical engineering programs interested in a doctoral career in biomedical sciences can become MARC trainees. Some of the proposed initiatives include on- and off-campus research experiences, weekly workshops on academic skills improvement, journal/book clubs, scientific dissemination among the general community, K-12 outreach and relevant RCR training. Recruitment strategy for prospective MARC students includes activities such as an orientation on biomedical research careers for freshmen and sophomores, and an integrative research summer workshops designed to encourage prospective trainees to develop new skills and methodologies in biomedical research areas. The UPRM MARC program also provides faculty with ample opportunities to enrich their science teaching and mentoring skills by fostering professional development activities. The objectives of the MARC U-STAR Program at UPRM are: 1) increase the knowledge (awareness) of freshmen and sophomore students from participating academic programs (PAP) about research careers and opportunities in biomedical sciences; 2) increase the excellence and number of biomedical researchers from the PAP actively engaged in training, mentoring and role modeling of the UPR-M MARC students; and 3) foster an effective undergraduate research environment through activities and experiences that develop a meaningful contemporary biomedical research culture.

Public health relevance
Project Narrative The MARC U-STAR@UPRM program will build a research culture to support honor students from science and engineering through meaningful research related experiences, a special science curriculum, scientific service learning and professional development activities that will improve their competitiveness in pursuing graduate programs in biomedical sciences. Some of the proposed activities include on- and off-campus research experiences, academic skills advancement workshops, journal/book clubs, scientific outreach, and integrative research summer workshops to raise awareness within the general student community about biomedical research careers. The MARC Program at UPRM will also provide faculty with opportunities to enrich their research and teaching skills by fostering best practices through mentoring and pedagogy role modeling activities.